Role of CYP2A and Hmox1 in the Diabetogenic Effects of Arsenic in Mine Tailings

ABSTRACT (Project 2: Xinxin Ding and Qing-Yu Zhang)
Environmental exposure to arsenic metalloids, the major toxic contaminants in mine tailings, is associated with
increased incidence of metabolic diseases in humans, posing a significant health risk to people living near
contaminated sites. Populations residing near mining sites may be exposed to mine tailings through the
inhalation of dust particles or ingestion of contaminated water or food, as the arsenic contaminants may become
bio-accessible and cause debilitating metabolic diseases such as diabetes. The diabetogenic potential of
arsenicals in environmentally-occurring mine tailing particulates is unclear, however, and the molecular
mechanisms underlying the diabetogenic effects of arsenic are not fully understood - knowledge gaps that have
markedly hindered disease prevention efforts. Nrf2, a master regulator of the antioxidant response, enhances
cellular protective mechanisms through the canonic pathway, leading to activation of many antioxidant and
biotransformation genes. Evidence also suggests, however, that Nrf2 may disrupt cellular homeostasis upon
prolonged activation via a noncanonical pathway activated by the dysregulation of p62-dependent autophagy.
The current study will test the novel hypothesis that Nrf2-stimulated protective mechanisms play an important
role in limiting the adverse impact of chronic arsenic exposure through the modulation of host metabolic
homeostasis and gut microbial arsenic biotransformation. Accordingly, we believe that the disruptive events
(studied in Project 1) and the protective mechanisms (Project 2) mediated by Nrf2 signalling are both important
determinants of the diabetogenic risk of mine tailing arsenic metalloids. Nrf2 target genes include those for
enzymes involved in the production or metabolism of bilirubin, including heme oxygenase 1 (Hmox1) and CYP2A
(mouse Cyp2a5 and human CYP2A6). Strong clinical and experimental evidence indicates the protective role of
bilirubin against the development of metabolic syndromes. Although transient, Hmox1 was drastically induced in
the intestine, but not in the liver, upon arsenic exposure in drinking water (25 ppm) (preliminary data). Cyp2a5
was among the most highly and persistently induced genes in the mouse liver following chronic oral exposure to
arsenic (preliminary data). These findings support the specific hypothesis that the induction of intestinal Hmox1
and hepatic CYP2A5/6 serves as an important counterbalance against the diabetogenic effects caused by
chronic Nrf2 activation by mine tailing arsenic metalloids. The hypothesis will be tested through three specific
aims. The outcome is expected to contribute to an integrated mechanistic view of the risk factors underlying
arsenic’s diabetogenic effects, and thus fill an important knowledge gap that has hampered disease prevention
efforts.

Public health relevance
PROJECT NARRATIVE (Project 2: Xinxin Ding and Qing-Yu Zhang) Environmental exposure to arsenic metalloids contained in mine tailings poses a significant health risk to people living near contaminated sites, as the arsenic contaminants may become bio-accessible and cause debilitating metabolic diseases such as diabetes. Validation of our hypothesis that the induction of intestinal Hmox1 and hepatic CYP2A5/6 serves as an important counterbalance against the diabetogenic effects of chronic mine tailing arsenic exposure will provide the foundation for development of novel approaches for disease prevention for people who live in contaminated areas.